Models and Gene Therapies for AAT Deficiency

Administrative Core
Project Summary
The administrative core will provide a structure for management of the financial aspects of this
complex multi-component program and create vehicle for communication among the
investigators leading each component. The administrative core will also convene both internal
and external advisory board members, as objective but informed scientists to provide
feedback to the P01 investigators about the strengths and weaknesses of each component
and to evaluate the progress of each component (and of the overall program) over time.

Public health relevance
Project Narrative Not Applicable.